Validation of blocking TSP4/Cava2d1 interaction as a new target for neuropathic pain

Project Summary/Abstract
Validation of a novel pain target is a critical step toward the development of new
nonaddictive, therapeutic agents for chronic pain management, which is an urgent unmet
medical need to be tackled by NIH's Helping to End Addiction Long-term (HEAL) initiative.
We recently discovered that nerve injury induced concurrent upregulation of the calcium
channel alpha-2-delta-1 subunit (CaV21) and thrombospondin-4 (TSP4) proteins in sensory
and spinal cord neurons that contributes to neuropathic pain development by inducing
aberrant excitatory synapse formation and sensitization of neurotransmission in spinal cord.
We have identified a target side in the TSP4 that plays a critical role in mediating these
pathological changes upon interaction with the CaV21 protein. To validate this novel target
site for development of nonaddictive pain medications, we plan to use multidisciplinary
approaches, involving three independent laboratories, to investigate if blocking and genetic
deletion of the target site can block/prevent (Aim 1) pain state development; (Aim 2) aberrant
excitatory synapse formation; (Am 3) spinal cord neuron sensitization after injury in two
neuropathic pain models. Successful completion of this project will provide important
information for further development of specific therapeutic medications for neuropathic pain
management as inspired and supported by the HEAL initiative.

Public health relevance
PROJECT NARRATIVE We plan to validate a new target for further development of target-specific, nonaddictive neuropathic pain medications in response to NIH's Helping to End Addiction Long-term (HEAL) initiative. We recently discovered that peripheral nerve injury induced concurrent dysregulation of the calcium channel alpha-2-delta-1 subunit (CaV21) and thrombospondin-4 (TSP4) proteins in dorsal root ganglia and spinal cord that contributes to neuropathic pain development by inducing aberrant excitatory synapse formation and pain-signal transmitting neuron sensitization. We have identified a target side in the TSP4 that plays a critical role in mediating these pathological changes upon interaction with the CaV21 protein. In this project, we plan to validate the role of this target site in mediating (1) pain state development in two neuropathic pain models; (2) aberrant excitatory synapse formation in vitro and in two neuropathic pain models; (3) spinal cord neuron sensitization after injury in two neuropathic pain models. Successful validation of this novel nonaddictive pain target will provide important information for further development of specific therapeutic pain medications as inspired and supported by the HEAL initiative.